INTRON A MONOTHERAPY VS INTRON A + RIBAVIRAN TREATMENT OF CHRONIC HEPATITIS C

The purpose of this study is to determine whether another drug called ribavirin will increase the effectiveness of interferon when the two medications are taken together for 6 to 12 months.